Web-based Atlas of Zebrafish Microanatomy as a Community Resource

DESCRIPTION (provided by applicant): The zebrafish is now a common, non-mammalian model of human disease due to experimental features such as small size, transparency, and powerful genetic tools. In response to NIH-sponsored Zebrafish and Aquatic Models working groups' recommendations, an important piece of American scientific infrastructure is being established in the form of a web-based atlas of anatomy, histology, and pathology. This atlas will be accessible from www.zfatlas.psu.edu and the Zebrafish Information Network (ZFIN) at the University of Oregon (www.zfin.org). Normal anatomy will serve as critical context for the study of abnormal anatomy caused by genetic deficiencies and disease. The atlas' personnel, imaging and computer hardware and web site comprise the infrastructure for users to view mutant/morphant/diseased zebrafish in the context of normal, in both 2D and 3D. Specific Aim 1 is to integrate abnormal phenotypes into the atlas starting with an established mutant collection, to create a nondestructive mechanism for remote labeling of web-based, state-of-the-art virtual slides that allows viewing of histological tissue sections at different powers, to integrate the zebrafish atlas with other web-based resources including the home of zebrafish web-based resources (www.zfin.org), and to use the web interface to display a range of mutant phenotypes. Specific Aim 2 is to develop mechanisms for analyzing and displaying 3D zebrafish data. We will segment and label different organs from digital 3D representations of zebrafish, and explore, test, and implement integrated interfaces between virtual slides and 3D representations of zebrafish created by microCT imaging at subcellular resolutions. Specific Aim 3 is to build a foundation for structural and functional integration across models systems. This aim will utilize zebrafish, mouse, and human as the organisms of interest, and use specific skeletal, eye, and skin color mutations as a paradigm for describing the roles of model systems in understanding a biological function and disease. This aim will focus on normal tissues shared by all three species followed by pathology shared by all three species. The integrations of this community resource will serve as a model for all model system web sites, serving multiple missions across the NIH.

Public health relevance
PUBLIC HEALTH RELEVANCE (provided by applicant): Compelling experimental features have made the zebrafish a model for a wide range of human maladies, including cancer, heart disease, and infection. The atlas (www.zfatlas.psu.edu) contains high-resolution 2D and 3D representations of normal and, as proposed, abnormal zebrafish. By cross-referencing with other model systems, the atlas will also provide infrastructure for integrative, multidisciplinary projects. Compelling experimental features have made the zebrafish a model for a wide range of human maladies, including cancer, heart disease, and infection. The atlas (www.zfatlas.psu.edu) contains high-resolution 2D and 3D representations of normal and, as proposed, abnormal zebrafish. By cross-referencing with other model systems, the atlas will also provide infrastructure for integrative, multidisciplinary projects. __SpecificAimsTextDelimiter__ Vision of cross-model integration and the zebrafish atlas: Morphology and its aberrations are important endpoints in the study of normal and abnormal function of genes and is central to our understanding of the pathogenesis of human disease. To accelerate the building of translational connections between model systems and human biology, we are pursuing the long-term goal of creating a web-based infrastructure for integrating knowledge of normal and abnormal structure and genetics across model systems. Here, we propose to continue building infrastructure for those integrations within the context of a powerful genetic model system, the zebrafish. Rationale: Many of the most profound revelations in the history of biology and medicine derive from the discovery of the cellular, or microanatomical basis of biological function and human disease (e.g. Virchow, 1860). Just as a knowledge of normal anatomy and microanatomy of the human body is essential for the physician to understand and treat human disease, knowledge of a model system's range of normal microanatomy is necessary for recognition of abnormalities associated with experiments. The zebrafish is a frequently chosen non-mammalian model of human disease because of its advantageous experimental features, including short generational time, fecundity, small size, transparency, and powerful genetic tools. These advantages facilitate the generation of mutants in forward genetic screens. Analysis of embryonic mutant and morpholino antisense knockdown phenotypes, as well as adult phenotypes (including those susceptible to infectious disease and cancer), can all benefit from availability of reference images of normal anatomy and microanatomy. A growing appreciation of the power of web-based resources has led zebrafish and aquatic model research working groups to call for a comprehensive web-based atlas of zebrafish microanatomy that includes histology. We have made substantive progress towards fulfilling this request with our current zebrafish atlas. The atlas will ultimately include every known cell type in every tissue and organ across the normal lifespan, contain representations of mutant, morphant, and disease phenotypes in comparison with normal, and use the power of web-based databases to connect model systems with each other and with humans. Zebrafish Atlas transition from Phase I to Phase II: Glass and state-of-the-art virtual histology slides of normal zebrafish comprise the foundation for the first phase of the atlas (see http://www.zfatlas.psu.edu). This work also includes the generation of 3D reconstructions from serial sections of embryonic and larval zebrafish. However, while the high resolution of tissue histology permits identification of organs through all stages of the lifespan of zebrafish, we found that variability in focal section-to-section distortion and human error in outlining organs made the generation of satisfactory reconstructions impractical. Furthermore, the tedious nature of this method of reconstruction prevents its use for rapid phenotyping of even younger mutants. Existing optical imaging methods without these problems are powerful in younger fish (24-48 hours old), but are not possible in older, normally pigmented fish, or lack the ability to visualize individual cells. Since the original proposal, however, we have found that micro computed tomography (microCT) imaging has the potential to give the average zebrafish investigator practical access to 3D representations of their abnormal fish at resolutions in which multiple individual cell types are visible. Here, we propose a second phase of the atlas focusing on the display of abnormal morphology in the context of comparisons with corresponding wild-type images, as well as the development of microCT-based, 3D reference images and methods. The latter will enable high-resolution 3D imaging of zebrafish to be readily adopted by the general research community. This phase of the atlas will establish infrastructure for integration across model organisms and be developed within the structure of three specific aims. Specific Aim 1 - Integrate abnormal phenotypes into the atlas. Subaim 1.1. Create an infrastructure for remote, dynamic, and database-linked labeling. In order to maximize the utility and facilitate sharing of data derived from the zebrafish atlas, user tools will be elaborated, including a nondestructive mechanism for remote labeling of virtual slides. Labels will be linked to a database of locations for every label, and formats will comply with anatomic and phenotypic ontologies. Members of the atlas team will label non-neuroanatomical structures, with confirmation by experts. Due to the complexity of the nervous system, the authors ofthe definitive texts of zebrafish neuroanatomy, Mario Wulliman and Thomas PHS 398/2590 (Rev. 11/07) Page 94 Continuation Format Page Program Director/Principal Investigator (Last, First, Middle): Cheng, Keith C. Mueller, will apply neuroanatomical labels. We will also continue to integrate the atlas with zebrafish web- based resources at www.zfin.orq . This subaim will continue through the life of the project. Subaim 1.2. Create a paradigm for display of abnormal phenotypes and disease for zebrafish. A primary purpose ofthe atlas is to facilitate recognition of abnormal structure. We will therefore develop matched sets of normal and abnormal histology slides, from normal cf mutant larvae from the Nancy Hopkins' insertional mutant collection at MIT (Amsterdam et al. 2004) as well as normal cf diseased adults (including cancer and infectious disease) from the Cheng and other laboratories, A comparative pathologist will label abnormalities. This subaim will also continue through the life of the project. Specific Aim 2 - Generate 3D microCT models of zebrafish. The 3D structure of tissues and organs is important to the understanding of organ morphogenesis and disease. In order to evaluate the relative practicality of existing technologies for routine use by the research community, we will continue existing collaborations with physicists at University of Chicago, Argonne National Labs (ANL) and Micro Photonics, Inc. Ongoing work seeks to optimize generation of reference microCT images using synchrotron-based, high-flux, monochromatic, parallel beam X-rays (ANL) and desktop-instrument-based, lower-flux, polychromatic, cone-' beam X-rays (Micro Photonics). Since 3D information is challenging to convey and perceive, we will explore, test, and implement integrated interfaces between virtual slides and 3D representations of zebrafish. Organs will t>e segmented and 3D representations will be generated using VGStudio Max and Amira software. Labels for organs and 3D structures will be confirmed with assistance from community experts. We will incorporate virtual slide labeling into visualization of 3D slice visualization in years 1 and 2. Refining remote 3D labeling, labeling of normal and a limited set of abnormal structures, and the addition of user tools that become apparent will comprise the balance of our efforts in subsequent years. Specific Aim 3 - Build a foundation for structural and functional integration across model systems. We will take advantage of the evolutionary conservation of histological structure to develop the zebrafish atlas as a platform for integration of normal and abnormal microanatomy and gene function across model-systems. To lay a foundation for this goal, atlas team members who are practitioners of comparative veterinary anatomic pathology and human anatomic pathology will extend the virtual slide comparison tools to comparison of histology and pathology slides between organisms, focusing on identification of virtual slide sets between zebrafish, mice, and humans. We will set up comparisons between each ofthe normal tissues shared by all three species, followed by comparisons of a pilot set of diseased tissues shared by all three species. We will incorporate existing virtual slides of normal and abnormal human and mouse tissues from Fred Dee (U lowa) and Robert Cardiff (UC Davis). Integration of data across model-system web sites will be facilitated by building lines of communication between the webmasters of different sites and by encouraging the creation of appropriate links. The generation of comparisons between zebrafish tissues and organs and the organs of other model systems such as medaka (another powerful fish model system) will be identified as time allows. To establish a mechanism for function-onented integration of microanatomy across species, we will use specific established skeletal, eye, and neural pathway mutants or morphants affecting homologous genes in fish, mice, and humans, starting with collaborations with Matthew Goldberger (Wash U St. Louis), Brian Link (MCWisc), Chi-Bin Chien (U Utah), and Steven Wilson (UCL, UK). Work towards this aim will continue throughout the funding period. Benefits to research and human health: The proposed atlas will contribute a broad range of benefits to research infrastructure that applies across virtually all of the Institutes of the NIH. Investigators using zebrafish, mice, and human tissues woridwide will gain access to normal controls and to tools for comparing normal with abnormal microanatomy. By creating the proposed infrastructure, the Zebrafish Atlas will enhance web-based resources, stimulate interdisciplinary collaboration, integrate morphological and other informatics across model systems, enhance the potential translational impacts of research with zebrafish and other model systems, and help translational researchers to find additional models of human disease.